Neutrophil Polarization Following Myocardial Infarction

Abstract
About one in four myocardial infarction (MI) patients progress to develop congestive heart failure,
which has a 5-year mortality rate of 50%. The goal of this project is to understand post-MI roles of
neutrophils by establishing how this cell type transitions in phenotype during wound healing spanning
from inflammation to repair. We hypothesize that neutrophils undergo a temporal phenotype
evolution that includes influencing post-MI inflammation resolution and ECM organization.
Specific aim 1 will map neutrophil polarization phenotypes over the post-MI time course. Aim 2 will
test the hypothesis that neutrophils actively contribute to inflammation resolution. Aim 3 will test the
hypothesis that neutrophils actively contribute to extracellular matrix organization during scar
formation. Innovation lies in the evaluation of neutrophil subtypes post-MI, which will allow us to
connect early neutrophil cell physiology to late remodeling outcomes. Multi-discipline approaches will
be integrated to explore the mechanisms whereby neutrophils regulate remodeling. This study will
drive forward the understanding of the cellular basis of LV remodeling and identify novel intervention
targets directed at neutrophils.

Public health relevance
Project Narrative Heart failure is the inability of the heart to pump adequately to supply the body with sufficient oxygen to meet its needs, and heart failure is a leading cause of death in the United States, the veteran population included. Of the 50,000 individuals diagnosed with heart failure each year, 70% of these patients have heart failure due to a previous heart attack (myocardial infarction; MI). The main objective of this grant is to use a mouse MI model to understand how one of the white blood cell types, the neutrophil, influences scar formation by regulating the wound healing response, particularly the inflammatory and reparative components.